Zebrafish Sensory Hair Cell Regeneration

Project Summary
Hearing loss and vestibular dysfunction are caused by death of sensory hair cells that in mammals fail to
regenerate. Therefore, there is an urgent need to develop techniques for regenerating hair cells in humans.
Promising progress has been made but the regenerated hair cells do not fully mature. It is therefore essential
that we gain a detailed understanding of the gene regulatory networks (GRNs) regulating hair cell
differentiation. In mice several transcription factors (TFs) regulate hair cell subtypes, such as TBX2 that
specifies inner ear hair cells (IHCs) and INSM1 and IKZF2 that are important for outer hair cell (OHC) fate
determination. How these TFs are regulated, how they interact with each other and what their direct targets are
is unknown. Also, as these factors are not sufficient to completely convert hair cell fates, additional co-factors
must exist. Zebrafish possess hair cells not only in their ears but also in the skin as part of the sensory lateral
line (LL) system. We and others have developed the zebrafish LL into a powerful model system to interrogate
the molecular mechanisms underlying hair cell regeneration. Our preliminary scRNA-Seq and TF motif
analyses show that the GRNs that regulate zebrafish lateral line versus ear hair cell identities share genes with
the mouse GRN that regulates IHCs versa OHCs, such as Insm1, Ikzf2 and Tbx2. In addition, we identified
prdm1a as a new regulatory factor controlling hair cell differentiation. Strikingly, loss of prdm1a leads to a
conversion of LL hair cells into ear hair cells via the activation of tbx2. Prdm1 is also expressed in mouse
progenitor cells but is turned off in hair cells. We hypothesize that the genes involved in the lineage decisions
that induce cells to differentiate from a common hair cell progenitor into organ-specific hair cell types are
regulated by similar core GRNs in zebrafish and mammals. Here we are proposing to characterize the GRNs
consisting of insm1a/b, ikzf2, prdm1a and tbx2a/b underlying hair cell subtype decisions in the lateral line and
ear, identify additional genes in the GRNs and functionally test key genes and enhancers. Importantly, building
cell type-specific GRNs during the regeneration time course will identify the injury-responsive upstream
regulators of the hair cell type-specifying genes. We will integrate single cell gene expression and chromatin
accessibility from the same cells at several regeneration time points to predict TF binding motifs in cis-
regulatory elements, linking TFs to enhancers and target genes. We will then computationally infer gene
regulatory networks and key TFs that control hair cell lineage commitment events in the LL and ear. TFs
predicted to play key roles will be functionally tested. In summary, our proposed experiments will construct
GRNs of hair cell subtype differentiation in the zebrafish in a regenerative context, which will yield candidate
factors essential for directing the differentiation of the correct hair cell types in various mouse sensory epithelia
during regeneration and organoid production. In addition, the comparison of the GRNs between the LL and the
ear will provide insights into how changes in regulatory elements drive the evolution of different hair cell types.

Public health relevance
Narrative Loss of sensory hair cells leads to hearing loss and vestibular problems. In contrast to mammals, zebrafish regenerate sensory hair cells. Elucidating the gene regulatory networks controlling zebrafish hair cell regeneration will help us to design therapeutic strategies to induce hair cell regeneration in humans.